An improved low-endotoxin Clean Genome E. coli strain for production of biological products

Abstract
E. coli has played a vital role in the production of recombinant proteins and plasmid DNA (pDNA) for therapeutic
use since the advent of the biopharmaceutical industry. E. coli remains the workhorse in the production of
heterologous proteins and pDNA because of its short doubling time, its ability to grow to high cell densities and
its relatively straightforward scale-up potential. About 30% of all approved therapeutic proteins and 70% of anti-
cancer agents continue to be made in E. coli. As the need for high quality pDNA has increased due to success
in gene therapy and mRNA vaccines, there is a growing need for high quality, low toxicity bacterial strains for
production of plasmids. The goal of this direct to Phase II application is to develop a versatile next-generation E.
coli strain built using Scarab Genomics’ Clean Genome® platform that combines low endotoxin levels with
enhanced genetic stability characteristics for nucleic acid and protein production. Specifically, we propose to use
genetic techniques to substantially lower the level of contaminating endotoxin in pDNA and recombinant protein
preparations.
Scarab Genomics has developed and patented its reduced genome E. coli strains, which has removed 650
potentially contaminating proteins and all transposable elements. We propose to further eliminate genes that are
responsible for the activation of the Toll-like receptor-4 (TLR-4). We propose that phosphorylation sites on lipid
A and on carbohydrates on the LPS side chains activate the Limulus amebocyte lysate (LAL) assay. These will
be removed and pDNA and protein products from this strain tested in a TLR-4 and LAL assay. Success of the
proposal will culminate in an E. coli strain that is low in endotoxin and increased genetic stability but continues
to generate high levels of nucleic acid and protein under fermentation conditions.

Public health relevance
The bacteria Escherichia coli (E. coli) continues to be a major vehicle used in the production of proteins and DNA in the biotechnology and pharmaceutical industry. However, improvements in genetic stability coupled with a reduction in deleterious elements unique to E. coli such as endotoxin would greatly improve and simplify its use. A E. coli strain that would encapsulate enhanced production characteristics and safety would greatly benefit the biopharmaceutical industry.